An Examination of Concomitant Non-Medical Use of Gabapentin and Opioids.

Project Summary/Abstract
Gabapentin is widely prescribed in neurology, psychiatry, and primary healthcare for the treatment of epilepsy
and neuralgia, as well as off- label during treatment for opioid use disorder (OUD) to mitigate withdrawal
symptoms, manage pain, and address patient anxiety. From 2002-2015, prescriptions for gabapentin tripled,
and gabapentin-involved opioid overdoses have also increased in recent years. As a result, starting in 2017,
multiple states reclassified gabapentin to Schedule V under state-controlled substances laws. In 2019, the
Food and Drug Administration required labeling changes for gabapentin that included a warning of potential
respiratory depression when used with opioids medications. Limited reports document non-medical use (NMU)
of gabapentin, especially among opioid users and individuals receiving medication assisted treatment (MAT)
for OUD. Gabapentin is non-medically used to potentiate the euphoric effects of opioids, including MAT
medications buprenorphine and methadone, as well as to self-treat OUD symptoms. Aside from these brief
reports, systematic studies examining the concomitant NMU of gabapentin and opioids are lacking. At the
same time, research documents the therapeutic benefits of administering gabapentin to individuals in treatment
for substance use disorder. Studies have shown that individuals receiving daily doses of gabapentin reported
decreased symptoms of withdrawal and gabapentin works well in combination with methadone for opioid
detoxification. Given the growing reports of NMU of gabapentin, especially NMU co-occurring with opioids and
MAT; the accepted use of prescribed gabapentin among treatment clients; and the dearth of systematic data
examining the concomitant NMU of gabapentin and opioids, the proposed exploratory R21 study seeks to
examine this phenomenon. The study will utilize a social ecology theory-driven design to investigate
motivations for concomitant NMU, gender and racial/ethnic differences, and histories of MAT and prescribed
gabapentin. The following specific aims will be accomplished: 1) Assess demographic, sociocultural, and
psychosocial characteristics across three social ecological domains (intrapersonal, interpersonal, and
community) which influence concomitant NMU of gabapentin/opioids; and routes of administration, modes of
acquisition, and consequences (n=150); 2) Construct and ethnographic decision model (EDM) of the decision
to initiate concomitant NMU of gabapentin/opioids (n=60); and 3) Examine NMU of gabapentin in combination
with MAT, including motivations, effects, and consequences (n=30). The sample will be collected among
individuals entering treatment for OUD and will include approximately equal numbers of men and women, as
well as, and Black, Hispanic, and white individuals. The study will advance Goal 1 of NIDA’s strategic plan by
identifying environmental, behavioral, and social causes and consequences of concomitant NMU of gabapentin
and opioids and it will be informative for OUD treatment providers and prescribers and aid in the development
of prevention and intervention strategies. This exploratory study is innovative in its use of EDM methodology.

Public health relevance
Project Narrative Recent epidemiologic and case reports suggest that gabapentin is non-medically used for several key reasons, but the potentiation of the euphoric effects of illicit and prescription opioids, especially medications used for medication assisted treatment for opioid used disorder (e.g., buprenorphine; methadone), appears to be especially dangerous. However, systematic and in-depth studies examining the concomitant non-medical use of gabapentin and opioids are lacking. By examining phenomenon, data from this study will contribute to public health knowledge of an understudied aspect of the opioid crisis, inform treatment practices for opioid use disorder, aid in the development of prevention and interventions strategies, as well as inform public policy initiatives.